Administrative Core

Administrative Core: Summary The Administrative Management Core will provide administrative and fiscal management for all projects and cores in this program, and facilitate and foster collaborative communications within the HIPC program and the broader academic environments. This core will provide program-specific administrative support including coordinating frequent interactions between projects, organizing regular monthly meetings of all the project and core leaders and personnel (both in-person and electronically), overseeing expenditures, and developing and organizing all scientific advisory board meetings as well as follow up communications, including documentation of the aforementioned activities. The main goal of this core will be to provide program-specific administrative support. The administrative staff of this core, overseen by the Program Director, will provide the necessary administrative support to coordinate the multiple groups in this program, including organizing regular meetings between project investigators and regular scientific advisory group meetings that will occur during the course of the program, beginning in year 2. The administrative core will also monitor and track program expenditures and progress on milestones, and assure regulatory and training compliance for this program. Thus, this administrative core will serve an essential cohesive function to coordinate all project and core investigators and activities in this program.